Characterization of Non-Protein Colloidal Plasma Volume Expanders

During the reporting year ending September 30, 2000, no work was performed on this project at CBER. However, as part of the validation of a new method of manufacturing Hetastarch drug substance, Fresenius Kabi Austria (FKA) has determined various weight average and number average molecular weight (Mw and Mn, respectively) values for 6 lots of their Hetastarch and 4 lots of innovator Hetastarch, supplied by CBER. FKA utilizes a complicated SE-HPLC method that requires a unique standard for calibration. Nevertheless, the resultant data now provide a way of assessing the ability of the commercial multi-angle laser light scattering-SE-HPLC (MALLS-SE-HPLC) method of Wyatt Technology, Corp. to accurately determine values for Hetastarch of Mn of the Fraction GTE 50,000, a value probably more related to potency (i.e. in vivo oncotic potential) than Mn of the Whole (or Mw of the Whole) since molecules of molecular weight LT 50,000 are rapidly cleared from the vasculature. We note that Wyatt's MALLS-SE-HPLC methodology allows the determination of relatively accurate values of Mw of the Whole (currently used for regulatory purposes) but does not permit accurate determination of Mn of the Whole due to the relatively low scattering efficiency of the lower molecular weight species in the SE-HPLC distribution.